LEARRN: Collaboration Between Other Institutions Component

PROJECT SUMMARY
LeaRRN is a collaboration between Brown University, the University of Pittsburgh and Boston University and
eight health systems partners within the Learning Health Systems (LHS) Innovation Hub. Brown University
would be the prime award recipient for LeaRRN, with sub-contracts issued to University of Pittsburgh and
Boston University. The specific aims of the Collaborations with Other Institutions Component are to: 1) facilitate
collaboration across institutions to insure that LeaRRN meets its infrastructure mission; and 2) facilitate
collaborations between health systems stakeholders and LHS rehabilitation researchers through the LHS
Innovation Hub that are based on mutual respect, trust, transparency, and open communication. LeaRRN’s
cross-institutional collaboration leverages the substantial resources and faculty expertise at each of our
separate universities, creating an integrated resource center with extraordinary breadth and depth and a
coordinated menu of resources and opportunities that is far greater than the sum of its parts. Stakeholder
members include the American Health Care Association, BAYADA Home Health Care, BMC Medical Center,
Cleveland Clinic, Johns Hopkins Medical Center, Intermountain Healthcare, naviHealth and University of
Pittsburgh Medical Center. Dr. Linda Resnik, proposed PI of LeaRRN, and PI of the Collaborations with Other
Institutions Component has the administrative and leadership experience to direct the proposed Center. Dr.
Resnik, Director of CoHSTAR, has also been PI of multiple large complex studies which involved VA Medical
Centers, academic institutions and a Department of Defense site. Dr. Janet Freburger will serve as site-PI of
the University of Pittsburgh team, and Dr. Mary Slavin will serve as site-PI of the Boston University team. Site
PIs will be responsible for the overall activities associated with the sub-contracts at their institutions and will
work closely with Dr. Resnik and financial administrative staff to insure that sub-contracts are properly
managed and resources used judiciously. Both site PIs are experienced researchers and team members who
will serve on LeaRRN’s Executive Committee. LHS Innovation Hub activities will be directed by Dr. Freburger
who will work closely with stakeholder members to facilitate communication and engagement with didactic,
pilot, mentored collaboration and techniques component activities. Coordination of activities across institutions
will be facilitated through regular meetings of component and LHS Innovation Hub members. Successful
collaborations across Brown University, University of Pittsburgh and Boston University will result in an
unparalleled national LHS rehabilitation research resource. The involvement of LHS Innovation Hub health
system partners throughout the research planning, implementation, and dissemination process will help ensure
that LeaRRN research is valued and translated into clinical care.